Research Symposia at the Annual Convention of the Hearing Loss Association of America

PROJECT SUMMARY
The Hearing Loss Association of America (HLAA) is the nation’s largest organization representing people with
hearing loss. The HLAA Convention, held annually, draws a broad national audience and is key to achieving
HLAA’s mission "to open the world of communication to people with hearing loss by providing information,
education, support and advocacy." Since 1994, each HLAA Convention has featured a Research Symposium
that covers cutting-edge scientific topics relevant to adults with hearing loss. These symposia are distinctive
because they are geared toward educating the hearing loss public about research. Often this is information
that people with hearing loss cannot get anywhere else. However, many members of the HLAA community
lack the time and resources to attend the convention. HLAA seeks NIDCD support to now bring the Research
Symposia to a broader audience, by producing high-quality captioned videos of the symposium talks. Videos
will be posted on YouTube and broadcast via Connected TV (accessible via Roku, Amazon Fire Stick, Apple
TV, etc.), and disseminated on channels such as Smart Senior Living and Healthy Living. In addition, HLAA will
promote viewing via local HLAA Chapter events and online webinars. Our specific aims are to present high-
quality, accessible Research Symposia at each HLAA Convention from 2019-2023 (Aim 1); harness
multimedia and other strategies to offer the content of the Research Symposia to those who cannot attend the
HLAA Convention in person, including HLAA members and the general public (Aim 2); and improve research
on hearing loss and hearing health by promoting engagement and dialogue between scientists and the
community of people with hearing loss (Aim 3). Although most R13 applications are submitted by scientists and
scientific or professional organizations seeking to engage with fellow scientists, this application is innovative in
that it is submitted by a robust and engaged patient organization that seeks to disseminate information about
scientific research to its members and the wider public.

Public health relevance
PROJECT NARRATIVE Hearing loss affects an estimated 48 million Americans. This project aims to spread information about the latest hearing loss research by creating professionally-produced captioned videos that are accessible to people with hearing loss. By posting the videos on YouTube, making them available on Connected TV (via Roku, Amazon Fire Stick, and Apple TV) and disseminating on channels such as Smart Senior TV and Healthy Living, more people will have the opportunity to understand and be engaged in research on this key public health issue.